SIP-24-003 Cancer Prevention and Control Research Network (CPCRN)

Emory Cancer Prevention and Control Research Network (CPCRN)
ABSTRACT
Despite the growing number of evidence-based cancer prevention and control interventions and strategies to
reduce the burden of cancer, most are not well adopted in local clinical or community settings. The Emory
CPCRN will increase the translation of cancer and lung cancer screening (LCS) evidence into local
communities. Wider use of effective interventions can significantly reduce cancer morbidity and mortality. The
Emory CPCRN has 5 inter-related aims and will: Aim 1. Collaborate with other CPCRN centers to advance the
mission of the CPCRN; Aim 2. Build the capacity of public health agencies, community-based organizations,
and cancer control research and practice networks to adopt and implement evidence-based strategies; Aim 3a.
Conduct a scoping review of lung cancer screening tools to measure eligibility for lung cancer screening; Aim
3b. Conduct a systematic review of interventions to promote lung cancer screening in the United States to
inform intervention development; Aim 4a. Conduct a survey of 20 primary care clinicians and lung cancer
experts to assess optimal, pragmatic lung cancer screening tools for LCS eligibility and optimal intervention
strategies for lung cancer screening; Aim 4b. Conduct a pilot of the LCS intervention with 20 patients to assess
comprehension, acceptability, and feasibility in a primary care center in Southwest, GA; Aim 5a. Design and
evaluate an intervention to promote lung cancer risk assessment, referral, and screening through a stepped
wedge, cluster RCT design in primary care clinics in rural, Southwest Georgia; and Aim 5b. Conduct
implementation research on program reach, adoption, implementation, feasibility, appropriateness, and
acceptability through surveys and interviews with primary care staff, using the RE-AIM model for sustainability
and equity and Consolidated Framework for Implementation Research. The Emory CPCRN proposed aims will
enhance the capacity of clinical and community organizations in Southwest Georgia and the state through
training, research, and dissemination efforts. We will contribute to an understanding of optimal lung cancer
screening tools and interventions through scoping and systematic reviews and a model for testing LCS
intervention strategies among primary healthcare centers to increasing LCS rates and reduce lung cancer
deaths.

Public health relevance
NARRATIVE Despite the growing number of evidence-based cancer prevention and control interventions and strategies to reduce the burden of cancer, most are not well adopted in local clinical or community settings. The Emory CPCRN will increase the translation of cancer and lung cancer screening (LCS) evidence into local communities and heath systems. We will conduct a scoping study of lung cancer screening tools, a systematic review of LCS interventions in the U.S., and a stepped wedge, clustered RCT to assess differences in lung cancer risk assessment, referral, and screening between the intervention and control groups to reduce lung cancer morbidity and mortality.